Characterization of non-canonical regulatory pathways in the Caulobacter NtrYX signaling system

Project Summary/Abstract
All bacteria must sense and respond to internal and external signals to thrive in diverse environments.
This sensing is often achieved using protein-based two-component signaling systems. Our funded parent project
is developing the Caulobacter crescentus NtrY-NtrX (NtrYX) two-component signaling system as a model for
understanding complex bacterial signaling pathways. Our aims seek to understand this atypical two-component
signaling system at multiple levels, from regulation of signal flow to changes in transcription. Although our aims
employ diverse biochemical and genetic methods, at their core they all require bacterial culture. Thus, a
functional and reliable autoclave for the preparation of growth media, sterile glassware, and sterile consumables
is key for the success of our project goals. This proposal seeks an administrative supplement to replace our
broken autoclave with a functional, high quality, and high-capacity autoclave appropriate for our laboratory
space. This new autoclave will be capable of meeting all sterilization demands for our parent grant and will also
help support additional microbial-related research and teaching in our department.

Public health relevance
Project Narrative Two-component signaling systems allow bacteria to respond to environmental changes, such as those experienced during host infection, and maintain homeostasis. The proposed work will examine the complex regulatory pathways governing a two-component system critical for the proliferation of many bacteria, including organisms relevant to human health, agriculture, and the environment. This research will expand our understanding of how microbes adapt to diverse environments and, in the long term, may aid in the development of future antimicrobial therapies.